ON BEHALF OF DCR FACILITATE THE CONDUCT OF AN OBSERVATIONAL STUDY TO CHARACTERIZE PATIENTS WITH COVID-19 INFECTION (10,000 SUBJECTS).

This funding supports INSIGHT Protocol Number 011, International SARS-CoV-2 Infection Observational Study (ICOS). this is an international observational study of adult outpatients with SARS-CoV-2 Infection.